Mapping Neural Circuit Activity Mediating MDMA's Prosocial Effect

PROJECT SUMMARY
3,4-Methylenedioxymethamphetamine (MDMA), known both as an `empathogen' and a demonized party
drug called `ecstasy', has now completed testing in a Phase 3 clinical trials as an adjunct to psychotherapy for
Post-Traumatic Stress Disorder (PTSD). Published data show that MDMA therapy has a rapid onset and a
large, durable effect size for patients with severe PTSD after even a single dose, attributed to MDMA's unique
ability to foster feelings of social connection, empathy and trust. However, MDMA itself may not be an ideal
therapeutic, as it has a well-known potential for abuse and is associated with cardiovascular and neuro-
psychiatric toxicity. Despite these and other limitations, the apparent efficacy of MDMA suggests that directly
enhancing sociability and social reward sensitivity are feasible, potentially powerful therapeutic strategies. In
mouse models we can use MDMA as a unique probe to understand evolutionarily conserved social behaviors
with potential therapeutic relevance. Conventional approaches to understanding the mechanism of MDMA and
other psychiatric drugs, focusing on high affinity receptor interactions and select brain areas, have had limited
success at developing novel therapeutics for psychiatric disease. My lab has developed a way to define
MDMA's mechanism with few assumptions about pharmacology or brain areas involved. This method, in mice,
maps brain-wide activity evoked during contrasting drug experiences and tests identified regions' requirement
for MDMA-linked behaviors. Combining social behavioral testing and imaging could be used to screen novel
therapeutics for MDMA-like profiles and provides testable hypotheses for human imaging studies with MDMA.
MDMA releases supraphysiological levels of serotonin (5-HT) and dopamine (DA) among other
neuromodulators and evokes acute social preference, social reward learning, and nonsocial drug reward in
humans and mice. Mechanistically similar drugs that primarily release 5-HT (d-fenfluramine, FEN) or DA (d-
methamphetamine, METH) recapitulate selective components of the total MDMA effect, but neither induces
social reward learning. Here, we propose to take advantage of the overlapping yet distinct behavioral and
pharmacological properties of MDMA, FEN and METH in order to understand MDMA's unique prosocial
effects. First, we compare brain-wide Fos expression maps between groups of mice under drug/environmental
conditions that highlight specific behavioral contrasts. We predict that the contrast between these drugs' effect
on brain-wide neural activity patterns correspond to these drugs' different subsets of MDMA-like behavioral
effects. Second, we test whether activity in identified regions is required for expression of four MDMA-evoked
behaviors: acute social preference, drug craving, social reward craving and social operant conditioning. My
preliminary data demonstrates proof-of-concept: we have discovered that the dorsal endopiriform nucleus/
ventral claustrum (DEn/VC) has an obligate role in MDMA-evoked acute social preference. Third, we detail the
anatomy and connectivity of the DEn/VC, and test whether its activity can suffice to drive prosocial behaviors.

Public health relevance
PROJECT NARRATIVE MDMA, known both as an ‘empathogen’ and the recreational drug called ‘ecstasy’, shows promise as an adjunct to psychotherapy for Post-Traumatic Stress Disorder, but it also has a potential for abuse, and may have adverse cardiovascular and neuropsychiatric effects. MDMA has unique effects on social behavior in humans, which we have modeled in mice. In this proposal we use MDMA as a probe to understand neural mechanisms of potentially therapeutic social behaviors, which may lead to safer treatment for a range of psychiatric conditions.